Beclin-1 in Sepsis-Induced Cardiac Dysfunction

Project Summary
Sepsis is a life-threatening condition of organ dysfunction caused by a deregulated host
response to infection. Our research is focused on understanding the mechanisms of
sepsis-induced cardiomyopathy, with an ultimate goal of developing new therapies.
In our recently published study in Circulation (May, 2018), we obtained strong evidence
showing that Beclin-1, a core regulator of autophagy, mitigates inflammation and
improves cardiac function during endotoxemia. We hypothesize that Beclin-1 is a
prospective new and key therapeutic target for sepsis-induced cardiac dysfunction. In
this application, we will test this hypothesis using both genetic and pharmacological
approaches in sepsis models in vitro and in vivo. We will determine the mechanisms of
how Beclin-1 protects the heart by a regulatory pathway via mitochondria-associated
membranes (aim 1) and by a selective induction of adaptive mitophagy (aim 2) during
sepsis. We will further perform a comprehensive preclinical evaluation for a newly
developed Beclin-1-activating peptide in clinically relevant models (aim 3). We expect
that these investigations will not only advance the fundamental understanding of sepsis
pathogenesis, but also identify a novel therapy with promising potential to improve
patient care quality and clinical outcomes for sepsis.

Public health relevance
Project Narrative Sepsis remains a leading cause of death in critical care units worldwide. In this proposed study, we will investigate the pathological mechanisms of sepsis-induced cardiac dysfunction and test a newly developed pharmacological therapeutic approach in animal models. This investigation will provide a solid foundation for the future clinical utility of a novel therapy in sepsis.